Stage II Efficacy Trial of a Culturally Informed Brief Intervention to Reduce Alcohol Related Health Disparities and Treatment Inequities among Latinxs

Abstract
Our prior Stage III Randomized Clinical Trial (n=1496) evaluating ethnic differences in response to
brief intervention showed that, compared to non-Latinxs Whites, Latinxs were more likely to reduce alcohol use
in response to standard brief alcohol interventions that are not adapted to be culturally responsive (NA-BMI)
versus treatment as usual1. In Stage I Community Based Participatory Research (Stage I CBPR), we
developed a culturally informed brief motivational intervention (CI-BMI) which adopts a harm reduction
approach and focuses on reducing alcohol problems and increasing treatment utilization 2. Through a flexible
core approach, CI-BMI introduces substantial modifications to standard brief alcohol interventions to be
culturally responsive and is theoretically grounded in self-determination theory (SDT)3-5. The result of Stage I
CBPR was CI-BMI which 1) leverages cultural values and strengths while addressing the process of
acculturation and acculturative stress; 2) is explicitly designed to meet the basic psychological needs of
autonomy, relatedness, and competence by supporting autonomy to enhance autonomous motivation to
change drinking behavior; and 3) focuses on harm reduction. Our Stage I CBPR (n=87) demonstrated that CI-
BMI is feasible and acceptable in pretesting in a Level I Trauma Center5. We hypothesize that CI-BMI will lead
to increased engagement in protective drinking behaviors, fewer alcohol problems as well as reduce barriers to
help seeking and increase treatment utilization among underserved, non-treatment seeking Latinxs who
engage in at risk drinking and are seriously injured. The proposed Stage II Efficacy Trial of CI-BMI will
randomize 600 Latinxs admitted to a Level I Trauma Center at University Medical Center in El Paso, Texas to
either NA-BMI or CI-BMI conducted by research staff from The University of Texas El Paso. Following
admission for medical treatment of an injury, eligible Latinx patients will be those who screen positive for
drinking at the time of their injury or engage in at risk drinking. The primary aims of the proposed study are to
1) test the efficacy of CI-BMI in comparison to NA-BMI on alcohol related harm reduction behaviors, alcohol
problems, barriers to help seeking and treatment utilization among non-treatment seeking Latinxs and 2)
examine the theoretically informed mechanism of behavior change based on SDT including providing
autonomy support to meet the basic psychological needs that enhance autonomous motivation. Because the
psychological processes underlying the intrasession mechanisms of change remain poorly understood, CI-BMI
based on SDT will significantly advance the science and practice of brief interventions6. In addition, planned
secondary data analysis will assess the influence of multi-dimensional acculturation/enculturation orientations
and acculturative stress on alcohol related outcomes. The results of this study will lead to a theoretically
informed and culturally response brief motivation intervention with enhanced generalizability to effectively
address alcohol related health disparities and treatment inequities among non-treatment seeking Latinxs.

Public health relevance
Project Narrative: This Stage II Randomized Efficacy Trial will compare the effectiveness of a theoretically informed and culturally responsive brief motivational intervention to a non-adapted brief intervention among non-treatment seeking Latinxs admitted for medical treatment of an injury who engage in at risk drinking or were drinking at the time of their injury. The culturally informed brief motivational intervention (CI-BMI) increases autonomous motivation to engage in protective drinking behavior and reduce alcohol problems while addressing barriers to help seeking and facilitating treatment utilization. This project will address the alcohol related health disparities and treatment inequities among Latinx who are more likely to experience alcohol problems yet less likely to receive treatment in order to reduce the negative public health impact of alcohol.